Development of machine learning software to quantitatively map telomere induced senescence in tissue sections during aging

Project Abstract
Cellular senescence is a key driver of many age-related diseases, yet its in vivo characterization
remains challenging due to cellular heterogeneity and the lack of universal biomarkers. Deep
learning classifiers based on morphological features hold promise for senescence detection, but
existing models are unable to accurately identify individual senescent cells in complex tissue
environments.
As part of a SenNet-funded Technology development award (TDA), we have developed
SenoQuant, an advanced AI-based analysis tool for multimodal imaging datasets. Using
SenoQuant, we integrated single-cell spatial proteomics technologies (4i and CODEX) to analyze
senescence-associated markers in human skin. From these data, we trained a deep learning
classifier capable of identifying p21+ senescent cells at single-cell resolution using only DAPI
staining, achieving 87% accuracy. Unlike conventional classifiers trained on in vitro datasets, our
model is the first to leverage spatial omics data to capture the complexity of senescent cells in
situ.
Building on this success, we aim to enhance the accuracy and expand the scope of our classifier
to detect a broader range of senescent cell types (senotypes). Utilizing omics datasets from aged
human skin and lung, including SenNet’s benchmarking project comparing spatial omics
technologies within the same tissue, we will develop more robust models. Additionally, we will
integrate our classifier into SenoQuant, providing researchers an easy-to-use, no-code required
solution to analyze DAPI-stained images and automatically quantify senescent cell burden.
These advancements will have profound implications for both fundamental research and
translational applications. By enabling cost-effective, high-throughput senescent cell detection,
our work will accelerate drug discovery, biomarker development, and diagnostics, ultimately
advancing our understanding of aging and age-related diseases.

Public health relevance
Project Narrative This project seeks additional funding to enhance AI tools for detecting senescent cells in nuclear- stained tissue sections. We will improve the accuracy and reliability of our deep learning models and integrate them into SenoQuant, our AI-based tool developed through the SenNet UG3 award. This advanced tool will enable researchers to efficiently quantify senescent cells, with potential applications in clinical research and therapeutic development.